COMBIN CHEMOTHERAPY AND DDI/DDC IN THERAPY OF AIDS RELATED KAPOSI SAR--ACTG 163

Phase I/II study of combination chemotherapy (Adriamycin, bleomycin, +/- Vincristine) and Dideoxyinosine (ddi) or Dideoxycytidine (ddc) in the treatment of AIDS-related Kaposi's Sarcoma.